Targeting Dyrk1a to Promote Donor-independent Platelet Production

Ex vivo production of platelets and megakaryocytes (Mk) offers solutions to the major clinical problems of
donor platelet shortages and scarcity of HLA-matched products. Multiple scientific breakthroughs have paved
the way toward this goal. The principal remaining roadblock consists of an intrinsic barrier to scalability.
Highly proliferative fetal-type Mk progenitors yield relatively few and hypofunctional platelets due to impaired
morphogenesis (e.g. enlargement and polyploidization); adult-type Mk yield more abundant and functional
platelets but have minimal proliferative capacity. An ability to safely circumvent these limitations, by combining
progenitor expandability with efficient platelet production, will be critical for cost-effective scale-up.
Accomplishment of this goal requires a detailed understanding of the molecular mechanisms underlying the
ontogenic switch, i.e. the transition from fetal to adult Mk morphogenesis. Control over this switch will enable
efficient scale-up by exploiting in a sequential manner the proliferative capability of fetal Mk followed by the
thrombopoietic potential of adult Mk. Our lab recently discovered a molecular basis for the Mk ontogenic
switch (Elagib et al. J. Clin. Invest., 2017). Specifically, an RNA-binding factor IGF2BP3 functions as a fetal-
specific master regulator by suppressing expression of the transcription factor MKL1, which orchestrates the
cytoskeletal remodeling of adult-type Mk. Pharmacologic repression of IGF2BP3 with BET inhibitors induced
MKL1 expression and adult morphogenesis but also caused growth arrest, compromising polyploidization. In
this proposal, we identify an alternative, improved approach of circumventing IGF2BP3 repression by
promoting nuclear translocation of MKL1. To accomplish this strategy, we have targeted Dyrk kinase activity,
which has been implicated in cytoplasmic retention of MKL1 and in Mk abnormalities in Down syndrome.
Pharmacologic Dyrk inhibition strongly enhanced cord blood Mk morphogenesis, ex vivo platelet release, and
in vivo platelet production in xenotransplanted immunodeficient mice. This approach also strongly enhanced
morphogenesis of iPSC (induced pluripotent stem cell derived) Mk, which normally have an early fetal
phenotype. Mechanistic studies using knockout mice and knockdowns in human progenitors support a critical
role for MKL1 regulation, mediated by Dyrk1a phosphorylation of Ablim2, an actin regulatory factor. The
critical influence of physical milieu, e.g. stiffness and shear, on Mk morphogenesis has been attributed to
MKL1 activation. Our results suggest that Dyrk1a inhibition provides a direct, potent, and tunable stimulus for
Mk morphogenesis that bypasses specialized culture requirements. This approach could thus obviate cost and
safety issues associated with specialized mechano-bioreactors. The proposed experiments will determine key
steps in Dyrk kinase control of MKL1 in iPSC and cord blood Mk, to permit optimal design of systems with
inducible Mk morphogenesis and platelet production. In addition, clinically feasible strategies for targeting this
pathway will be rigorously tested for Mk morphogenesis and platelet production in cord blood progenitors.

Public health relevance
Project Narrative Shortages of platelet transfusion units currently constitute a major clinical problem that is predicted to reach crisis proportions in the near future. Large investments have been made in techniques for producing platelets from cell culture systems, i.e. donor-independent platelets. However, preliminary successes in small scale production have not been translatable to the large scale approaches necessary to meet clinical demands, due to challenges in culturing the platelet-producing megakaryocytes. Specifically, human fetal-type megakaryocytes grow rapidly but produce platelets poorly, while adult-type megakaryocytes grow poorly but produce platelets relatively efficiently. We have recently discovered key molecular differences between these two types and have identified signals that can be triggered to shift type. This proposal will determine how these signals work to cause the shift and how they can be exploited to scale up production to meet clinical needs.